Technology Development Component

Project Summary—Collabotating Institutions
The proposed Center for Smart use of Technologies to Assess Real-world Outcomes (C-STAR) will serve as a
national resource to help investigators employ technologies to measure and interpret data relevant to
sensorimotor and cognitive function in the lab, clinic, and real world. This will be accomplished by leveraging our
broad expertise in the clinical, social, and technical sciences. The Shirley Ryan AbilityLab (SRAlab) is the focal
point of this expertise as it is where many of our clinicians and scientists, together with our many patients, are
collocated; however, C-STAR participants will also benefit from expertise that extends far beyond the SRAlab.
We will leverage our many external collaborations to facilitate our Center's mission and maximize our impact.
The majority of our external collaborations are with Northwestern University, which has a long record of research
and leadership in the movement, rehabilitation, and cognitive sciences. SRAlab clinicians and scientists regularly
partner with faculty from Northwestern University Schools of Engineering, Medicine, and Communication, and
many of our personnel hold appointments at both institutions. In addition, the translational nature of our research
has led to partnerships with companies that are developing instruments for assessing and augmenting
sensorimotor and cognitive function. Our collaboration plan draws on these existing connections to expand the
opportunities and expertise that C-STAR can provide to the rehabilitation research community. The goals of
these collaborations are to: (1) coalesce local expertise to meet challenges in design, implementation, and
interpretation of measures of sensorimotor and cognitive deficits. This will be accomplished by combining
expertise from colleagues in both insitutions (SRAlab and NU) and (2) develop a network of companies that can
help C-STAR participants translate ideas to practice. Expertise within C-STAR will be organized into four Cores:
Engineering, Clinical, Outcomes, and Implementation Science and Community Engagement. These cores
represent not only our expertise but also the domains of knowledge we believe are critical for deploying the smart
(i.e., appropriate, accurate, and clinically meaningful) use of technology for assessments in the real world. We
will leverage existing collaborations with colleagues at Northwestern University with wide-ranging, deep
experience across all Cores, providing expertise and mentorship to C-STAR participants who apply for pilot
funding or participate in collaborative research or sabbaticals, and contributing to C-STAR didactic resources on
use of technology in rehabilitation. Our industry contacts provide us with established conduits for translational
science, and we will leverage these connections to provide advice and opportunities to C-STAR participants for
commercialization of technologies developed, tested, or validated by our participants. In summary, we believe
that the C-STAR collaborations will be a major asset to our program and its participants. Our connections to
Northwestern University and to industry expand our pool of expertise and broaden the network of scientists and
engineers working on challenges related to the smart use of technology in rehabilitation.